PROMIS oral health toolkit-supported school-based oral health program

Abstract
Dental disease disproportionately affects low-income, underserved and minority children. Schools have been
an effective venue for childhood health surveillance and delivery of oral health services. However, traditional
surveillance methods are costly and require use of oral health professionals, which limits their ability to screen
large populations of children on a periodic basis. Similar constraints also limit the extent to which dentist-based
school oral health programs can be used for student populations. Thus, there is an urgent need for a more
efficient, feasible and accurate oral health screening approach that can distinguish abnormal from normal oral
health conditions and classify children into different levels of oral health treatment need so that they can be
referred for timely and appropriate dental treatment. Building on our Oral Health PROMIS (Patient Reported
Outcomes Measurement Information Systems) project, which has developed the nation’s first oral health
item bank systems and initial effective oral health screening toolkits for children, we aim to establish and test a
School-Based Oral Health Program (SBOHP) that includes efficient oral health screening, education, case
management and referral. This novel SBOHP will (i) apply innovative Oral Health PROMIS toolkits (short
form and computer adaptive testing) to efficiently and accurately identify dental problems and determine the
urgency of dental treatment need; (ii) deliver effective and pertinent oral health education tailored to students’
dental treatment need urgency and parents’ health literacy levels to enhance their understanding of the
importance of oral health and improve their oral health behaviors; and (iii) use school healthy start coordinators
and school nurses to provide case management, referrals and follow-up with available dental hubs and
treatment sources. This SBOHP will be developed and tested among students in the Los Angeles Unified School
District (LAUSD), who participate in the SBOHP at baseline and 12-month follow-up, to evaluate feasibility,
participation rate, efficiency, changes in oral health status, oral hygiene and diet behaviors, having or use of a
dental home, and oral health status. The study will be carried out in two phases. Phase I—Preparation Phase
will incorporate risk assessment into our existing case-finding-based treatment referral decision making;
calibrate Oral Health PROMIS toolkits to fit conditions manifested in the LAUSD student population; validate
the accuracy of OH PROMIS toolkits in identifying untreated caries and assigning students to treatment referral
categories against dental examination; and develop the procedures, protocols, and documents for testing and
evaluating the innovative SBOHP. Phase II—Testing and Evaluation Phase will evaluate feasibility,
acceptability and efficiency of the Oral Health PROMIS assessment toolkits-supported SBOHP, and the impact
of the SBOHP on children’s oral health status and care over time. The study has great potential to provide
critical surveillance information and serve as a model for feasible, acceptable, efficient and sustainable school-
based oral health programs for large populations of children across the country.

Public health relevance
Relevance to Public Health This study proposes a highly innovative school-based oral health program that uses oral health PROMIS (Patient Reported Outcome Measurement Information System) toolkits to conduct oral health screening which can resolve the long-lasting challenge of using unfeasible and high cost oral health professional-based examination in screening programs. The study has great potential to provide critical information for school oral health programs and can serve as a model for a feasible, acceptable, effective and sustainable school-based oral health program that can be implemented in large populations of children across the country.